Older Sexual and Gender Minority Patients with Serious Illness: Program-Building to Identify and Address Needs

This NIA K07 Academic Leadership Career Award resubmission entitled, “Older Sexual and Gender Minority
Patients with Serious Illness: Program-Building to Identity and Address Needs,” seeks to help these
understudied and underserved groups of patients, who, in the face of advanced age and serious illness, are
more likely to be single, living alone, without children, lacking in social support, and at risk for and fearful of
discrimination. The applicant is a senior physician at Mayo Clinic and has a long track record of research in
studying symptoms and psychosocial issues in ill patients (400+ publications), mentoring (50+ mentees +
principal investigator/program director of career development program K12CA090628-20), and serving as a
leader in both her home institution and nationally. This track record and these experiences are brought to this
application with the goal of understanding and addressing the unmet needs of these groups of older sexual
and gender minority (SGM) patients – defined by the NIH as “individuals who identify as lesbian, gay, bisexual,
transgender, two-spirit, queer, and/or intersex.” A uniquely rich institutional environment that includes the
Kogod Center on Aging; the Mayo Clinic Cancer Center (an NCI-designated comprehensive cancer center); a
robust Center for Clinical and Translational Science (CCATS); a nationally renowned statistics and data center;
the robust Mayo Clinic practice, which provides depth and breadth of clinical expertise in the management of a
vast array of serious illnesses to over 1 million patients per year; and, last but not least, the 120,000+ (and
growing) social media platform, Mayo Clinic Connect -- perhaps the largest such patient-centric electronic
medical resource in the world -- will set the stage for the development of this programmatic infrastructure.
Novel, ground-breaking research early in the grant-cycle will consist of a needs-assessment that uses both
qualitative and quantitative methodology to learn the unremitting symptomatology and unrelieved psychosocial
hardships of these older patients and that relies on Mayo Clinic Connect (an estimated 30% of users self-report
as 65+ years of age) to reach older SGM patients anonymously and to learn confidentially about their
concerns. This needs assessment will give rise to a series of annual requests for pilot grant applications
aimed at young investigators. Young investigators who are awarded a pilot project will acquire mentoring from
the applicant, engage in coursework, participate in a weekly seminar series, learn from a biannual visiting
professor series, begin to learn to contribute to CCATS course development on older SGM patients, and
further launch their careers as investigators in this field. National/international experts in their respective fields
and a patient advocate will serve on an advisory committee, providing programmatic guidance over the 5-year
grant cycle. These efforts are destined to establish a sustainable, funded research program to improve the
lives of older SGM patients with serious illness.

Public health relevance
PROJECT NARRATIVE Older sexual gender and minority patients with serious illness are understudied and underserved. Here we propose a career development program to recruit younger investigators to focus on these patients and help improve their lives.